CRISPRi-based discovery and in vivo validation of drug targets in M. abscessus

Project Summary
Non-tuberculous mycobacteria (NTM) are an emerging group of related opportunistic pathogens
that cause TB-like pulmonary infections, particularly in patients with underlying comorbidities such
as HIV or cystic fibrosis. Pulmonary disease caused by NTM is estimated to be 10 times more
common than tuberculosis in the U.S., with ~150,000 cases per year. Mycobacterium abscessus
(Mab) is responsible for >80% of all pulmonary disease due to rapidly growing mycobacteria and
is the predominant NTM pathogen in CF patients. Typical treatment plans include a multidrug
combination of injectable and oral antibiotics administered for up to one year. Treatment failures,
which occur in 50-70% of cases, often leave physicians with no recourse but to perform lung
resections. Clinical isolates of Mab are notoriously resistant to many classes of antibiotics,
including drugs effective against other mycobacteria (e.g. M. tuberculosis). Even antibiotics that
kill Mab in vitro are not very efficacious against in vivo infections. We hypothesize that this is due
to inducible drug resistance mechanisms that may be activated during infection (i.e. within
macrophages) or upon exposure to the drug. An important knowledge gap that hampers the
discovery of new, clinically effective therapeutics for Mab infections is the lack of validated drug
targets. This would entail demonstration of the essentiality of a gene product, at least conditional
essentiality in vivo, and assessment of its “druggability” or vulnerability to inhibition. This proposal
seeks to implement a powerful genetic tool, CRISPRi, for the first time in Mab to facilitate inducible
knockdown of targeted genes. In Aim 1, following evaluation and optimization of the CRISPRi
platform in Mab, we will demonstrate its utility for validation of drug targets and assessment of
their vulnerability of inhibition. In Aim 2, we will establish proof-of-concept for CRISPRi-mediated
gene knock-downs in vivo in a novel mouse model of pulmonary Mab infection. If successful, this
will yield a valuable tool for rapid genetic analyses in Mab as well as insights that will help to
overcome the impressive antibiotic resistance of this pathogen.

Public health relevance
Project Narrative Mycobacterium abscessus, an emerging pathogen in the non-tuberculous mycobacteria (NTM) group of microorganisms, causes TB-like pulmonary infections particularly in cystic fibrosis patients. M. abscessus is notorious for its high-level resistance to many different classes of antibiotics and available therapeutics only achieve a 30-50% cure rate. This project will develop a molecular tool for the inducible knock-down of targeted genes in vitro and in vivo to identify and prioritize novel targets for new antibiotics.